Glycemic Variability and Fluctuations in Cognitive Status in Adults with Type 1 Diabetes

Despite clear scientific and public health pertinence, the real-world effects of glycemic excursions on cognitive
status in adults with type 1 diabetes (T1D) are poorly understood. There is a critical need to identify glycemic
determinants of cognitive variability in T1D. Our long-term goals are to provide evidence-based guidelines for
monitoring cognitive status and preventing cognitive impairment in adults with T1D. Our objective for the
proposed study is to characterize the impact of glycemic excursions on cognition in T1D and determine
mediators and moderators of this relationship. This work is enabled by the development and availability of
continuous glucose monitor (CGM) devices that can provide real-time data about glycemic status and change-over-
time. Our central hypothesis is that glycemic excursions (hypoglycemia, hyperglycemia and rapid
glycemic change) in adults with T1D are associated with fluctuations in cognitive status. We further
hypothesize that glycemia-related cognitive variability is influenced by both acute psychological state (stress,
negative affect, and fatigue) and chronic diabetes-related (HbA1c, duration, complications) factors. Glycemic
excursions are expected to impact cognition more when cognitive resources are depleted (e.g. by stress) or
among those with lower levels of cognitive reserve due to the adverse neurological effects of diabetes. We will
test our hypotheses via ecological momentary assessment (EMA) with multiple brief daily objective cognitive
(processing speed, working memory, and cognitive control) and psychological state (stress, negative affect,
fatigue) assessments during concurrent blinded Dexcom G6 CGM, in 200 adults with T1D. We take advantage
of neuroscience-based self-administered cognitive tests that are validated on mobile devices for remote data
collection. We will accomplish this work through the following Specific Aims: 1) Characterize the relationship
between glycemic excursions and cognitive status. We predict cognitive performance will be poorer during
hypoglycemia, hyperglycemia, and when glucose is rapidly changing. 2) Determine how state variables
(stress, negative affect, and fatigue) impact the relationship between glycemia and cognitive status.
We predict that time-varying factors that reduce available cognitive resources (e.g. stress, negative affect,
fatigue) will either explain (mediate) or amplify (moderate) the relationship between glycemia and cognitive
status. 3) Determine if diabetes-related factors moderate the association between glycemia and
cognitive status. We predict that diabetes-related disease factors will be associated with greater impact of
glycemic excursions on cognitive status due to reductions in cognitive resources. This study will allow us to
determine how glycemic excursions impact cognition, as well as to identify mediators and moderators of this
relationship that could lead to novel interventions. Such an understanding will be necessary to maximize day-to-
day cognition, functional status, and quality of life. It will also lead to an empirically supported self-management
tool for tracking cognitive status that can be rapidly translated to clinical care.

Public health relevance
The proposed research is relevant to public health as it will provide insights into how glycemic excursions impact cognitive status in adults with type 1 diabetes. The proposed work will identify mechanisms for glycemia-related cognitive impairment in adults with type 1 diabetes and inform the development of novel tools that could be used to understand how changes in glucose impact daily functioning. The project is relevant to NIDDK’s mission because it will contribute new knowledge and a practical patient-centered tool that will improve the health and quality of life of people with diabetes.